Extracellular Vesicle and Extracellular RNA Biomarkers of HIV-1 Central Nervous System Pathogenesis and Cigarette Use

ABSTRACT
The HIV-associated neurocognitive disorders (HAND) and other neurologic disorders are predicted to affect
a majority of HIV-infected individuals at some time during the lifespan. These disorders occur despite effective
virologic suppression by antiretroviral therapy (ART). Yet few established biological markers. Recalling that
plasma biomarkers developed for AIDS (viral load and CD4+ T cell count) were essential in developing
treatment paradigms for AIDS, an intensified research focus on biomarkers of neurologic disease is warranted.
Improved biomarkers may be particularly important when substance use disorders (SUDs) are comorbid with
HIV disease. Among HIV+ individuals, cigarette smoking is several times more prevalent than in the general
population and contributes to inflammation and senescence processes that exacerbate pathogenesis in
multiple organ systems. Promising classes of biomarkers include stable extracellular RNAs (exRNAs), a
portion of which are packaged into extracellular vesicles (EVs) that can leave tissue such as brain to be
found in easily accessed biological fluids. These entities receive increasing attention as markers of neurologic
disease because of roles in neurodegeneration and (for EVs) because they can be traced back to a cell or
tissue of origin. Two categories of exRNA are particularly attractive because of their extraordinary stability:
microRNAs (miRNAs) and circular RNAs (circRNAs). miRNAs have been studied in HIV disease and SUDs,
but not in EVs of brain tissue, and almost nothing is known about circRNAs in HIV-1 pathogenesis or SUDs. In
this project, we will develop a catalog of biomarkers of HIV-1 pathogenesis and cigarette use and identify how
cigarette use may complicate interpretation of biomarker tests. Archived samples from a well characterized
animal model and human cohorts will be tested to identify and validate candidate biomarkers. Our expertise is
in HIV-1 disease and animal models; biomarkers of neurologic disease; EV techniques and biology; and
noncoding RNAs. We will first use a novel tissue EV isolation technique to seek candidate molecular
signatures of EVs and exRNA in brain tissue (Aim 1), and then investigate EV and exRNA signatures in
matched, longitudinally collected cerebrospinal fluid and blood plasma (Aim 2). Importantly, Aim 3 investigates
human samples in parallel. the project will address current gaps in the literature in rigorous and reproducible
fashion by ruling out common artifacts of EV and exRNA analysis and through cutting edge confirmation of the
identity of isolated EVs. Overall, we hypothesize that brain-derived EVs and their most stable exRNA
cargo, miRNAs and circRNAs, serve as biomarkers of HIV-associated neurologic disorders. Since some
markers will also be associated with cigarette smoking, tobacco use will be investigated for possible interfering
effects on measurement of neurologic disease biomarkers.

Public health relevance
NARRATIVE Novel biomarker tools are needed to diagnose and predict the progress of HIV-associated neurologic disorders, which persist despite effective control of HIV by antiretroviral therapies and are exacerbated by co- morbid substance use disorders such as tobacco smoking. In this application, we will use cutting edge technologies to develop extracellular vesicles and highly stable extracellular RNAs (microRNAs and circular RNAs) as biomarkers of neurologic disease. Matched tissue and biological fluids samples from a powerful animal model of HIV disease as well as fluids samples from human cohorts will allow us to identify biomarkers and learn how cigarette smoking affects them.